ANGIOTENSIN CONVERTING ENZYME INHIBITION IN DIABETIC NEPHROPATHY

The specific aim of this study is to determine if either of two levels of blood pressure control are preferable in patients with established type I diabetic nephropathy with respect to the rate of decline of renal rundtion, rate of end stage renal failure, morbidity, mortality and the clinical course of proteinuria